Administration and Management

ADMINISTRATION AND MANAGEMENT SUMMARY
Our goal is to develop a plan for administration and management to ensure that the biotechnology research
resource operates productively and efficiently. We propose a clear organizational structure that encourages
collaboration within and between technology development teams to drive rapid progress in technology
development, DBPs, and community engagement efforts. We refine our established protocols for evaluating
and selecting collaboration, service and driving biomedical projects. We propose an External Advisory
Committee composition that will provide the expertise needed to provide advice and guidance across the full
range of BTRR activities. We develop a sustainability plan to ensure that our technology persists beyond the
lifetime of the resource.